MRI Study of Normal Brain Development

Four NIH Institutes (NICHD, NIMH, NINDS, and NIDA) jointly sponsored a multicenter study to advance our understanding about how the brain develops in typical, healthy children and adolescents. This study enrolled approximately 500 children, ranging from infancy to young adulthood, who were seen at different time points over a six-year period at several clinical centers around the U.S.. Magnetic Resonance Images (MRI) of the brain were acquired and the imaging findings and standardized neuropsycological tests were administered. Our role in this clinical research project has been to serve as a Diffusion Tensor Data Processing Center (DPC). This entails processing and analyzing all diffusion tensor MRI (DT-MRI or DTI) data that were acquired by the various clinical Centers during the course of the study. Previously, we developed and implemented a DTI data processing pipeline. Specifically we developed procedures for sorting, displaying, and co-registering diffusion weighted images (DWI) from which the DTI data is computed. The image registration procedure accomplishes the tasks of removing the effects of subject motion and eddy current distortion as well as aligning the images to a given template with only one interpolation step, ensuring minimal loss in data quality. We also proposed a new strategy for robust estimation of the diffusion tensor and quantities derived from it. We addressed the task of registering DTI data to other structural MRI data contained in the database using rigid body and linear (affine) transformations. More recently we addressed the task of correcting residual image distortion originating from the Echo-Planar DWI (DW-EPI) acquisition used for DTI. In 2005 the project was awarded Neuroscience Blueprint funds to expand the DTI portion of the study. The original DTI data collection was limited to only a 10-minute protocol performed on those subjects able to tolerate additional time in the scanner following the collection of the core structural MRI data. This recent expansion has improved the quality of data collected through longer or additional scanning sessions for older subjects, and through the recruitment of new subjects and scanning sessions for the younger cohort. Our group designed the expanded DTI acquisition protocol and coordinated its implementation at each clinical site where DTI data was collected. We have developed our DTI processing software (TORTOISE) and have disseminated it to the public through the website https://science.nichd.nih.gov/confluence/display/nihpd/TORTOISE . The software is actively maintained and has an increasing number of registered users. All diffusion data from the Normal Pediatric Brain MRI project have been successfully processed using the TORTOISE pipeline and have been deposited in a database that is accessible by the greater scientific community. Our group is now preparing age-specific brain atlases from these data and and investigating developmental trajectories for several brain regions.